Bioinspired selective heterogeneous organic photoredox catalysis

Project Summary PI: Deria, Pravas
Photoredox reactions offer unique opportunities to develop synthetic routes for new drug
discoveries that are otherwise unattainable via C-C bond formation through sp3 C-H and C-X (X
= halogen) activations. However, current methodologies that employ metallic (such as ruthenium
and iridium) complexes or explicit organic photosensitizer (PS) entail two critical challenges
relevant to the implementation of atom-economic stereoselectivity (critical for biomedical activity)
and easy separability and recyclability (required for large-scale syntheses). Heterogeneous
photocatalysts with enzyme-like selectivity are required but remained elusive –mainly due to
diffusion-related challenges where, unlike thermally activated transformations, the reactants,
substrates, and chirality-inducing groups need to come close within a short (typically nano-to-
microsecond) timescale. We propose to address the incumbent challenges with porous crystalline
molecular frameworks as a photosensitizer to drive selective catalysis within their well-defined
pore cavities.
The diffusion-related challenge and relevant photophysical requirements are addressed
within certain crystalline metal–organic frameworks (MOFs) where tens of photoactive linkers
serve as light-harvesting antennas. The photoexcited energy transfer (also treated as molecular
exciton migration), along the preferred direction of the molecular diffusion, can be tuned and
primed. Efficient preferential exciton mobility can leverage the need for PS diffusion required to
excite the substrates. Therefore, this AREA proposal will pioneer novel MOF compositions that:
(i) control optoelectronic properties as a function of framework structure critically required for
heterogeneous photoredox catalysis, (ii) elucidate the generality of the MOF photocatalytic
reaction and products accessibility, and (iii) unveil the critical microenvironment needed for
stereoselective transformations. Endowed with molecular-scale porosity and tunability, MOFs
provide scalable, well-defined, modular heterogeneous platforms for fundamental photochemical
developments. The methods, combining molecular assemblies to harvest light driving
photochemical transformations within its confined, yet selective porous cavity, will provide
transferrable and potentially transformative fundamental knowledge for developing recyclable and
selective heterogeneous photocatalysts for the discovery of life-saving drugs.
Project Summary/Abstract

Public health relevance
Project Narrative PI: Deria, Pravas The ability to synthesize new asymmetric molecular structures, with selective and precise control over spatial arrangements of its atoms, is the primary requirement for life-saving drug discovery. The proposed research will use solid molecular frameworks as readily scalable and separable photocatalysts to drive spatially selective reactions by hosting the reactive intermediates within their precisely designed asymmetric pores. We anticipate the research on developing selective heterogeneous photocatalysis will have both fundamental chemical and biochemical scientific impacts as well as practical impacts in new drug discovery. Project Narrative